Mechanisms of skin penetration in skin-penetrating parasitic nematodes

PROJECT SUMMARY
Skin-penetrating nematodes, including the human-parasitic threadworm Strongyloides stercoralis, infect nearly
one billion people worldwide and are a major source of morbidity in low-resource settings. Infections can cause
chronic gastrointestinal distress, stunted growth and cognitive impairment in children, and even death in the case
of S. stercoralis infection. Skin-penetrating nematodes have a soil-dwelling infective third-larval stage that
actively searches for a host to infect using host-emitted sensory cues, and then invades the host by penetrating
directly through the host’s skin. Host invasion via skin penetration is an essential step of the parasitic life cycle,
yet remarkably little is known about this process. We propose to investigate the behavioral, neural, and molecular
mechanisms that mediate skin penetration in S. stercoralis and the closely related rat parasite Strongyloides
ratti. We will leverage new methods we recently adapted for mechanistic studies of these species, including
methods for CRISPR/Cas9-mediated targeted mutagenesis, reversible chemogenetic neuronal silencing, and in
vivo calcium imaging. In Aim 1, we will elucidate the behavioral program that leads to skin penetration using in
vitro and ex vivo skin-penetration assays. We will compare the behaviors of S. stercoralis and S. ratti infective
larvae on host vs. non-host skin to identify behavioral sequences specific to host skin. We will also compare the
responses of infective larvae vs. non-infective life stages to identify behaviors that are specific to infective larvae.
Finally, we will compare the behaviors of S. stercoralis and S. ratti infective larvae to those of distantly related
skin-penetrating infective larvae, passively ingested infective larvae, and free-living larvae to gain insight into the
evolution of skin-penetration behavior. In Aim 2, we will investigate the role of dopamine signaling in regulating
skin-penetration behavior. We will test the hypothesis that the Strongyloides dopaminergic neurons are
mechanosensory neurons that detect the texture of the skin surface and initiate skin-penetration behavior upon
contact with host skin. We will also functionally characterize the response properties of the dopaminergic neurons
upon contact with host skin. In Aim 3, we will identify and functionally characterize the mechanosensory neurons
and mechanotransduction pathways that recognize specific mechanical features of host skin and enable the
infective larvae to burrow through the skin. We will also compare mechanosensory function in Strongyloides spp.
and the free-living nematode C. elegans to pinpoint the specific mechanosensory adaptations of the parasites
that support skin penetration. Together, our results will provide key insights into the molecular and neural
mechanisms by which skin-penetrating nematodes invade hosts, which may inform the development of novel
topical anthelmintics.

Public health relevance
PROJECT NARRATIVE Skin-penetrating parasitic nematodes infect nearly a billion people and are a major cause of morbidity worldwide. This grant will investigate the behavioral, neural, and molecular mechanisms that underlie the process of skin penetration in these parasites. Our results will illuminate how skin-penetrating nematodes invade human hosts and may enable the development of novel nematode control strategies.